The Ghana Randomized Air Pollution and Health Study (GRAPHS) Cohort

Household air pollution (HAP) results in an estimated 2.3M deaths every year. A large proportion of HAP-attributable deaths are due to respiratory disease over the life course. Establishment of optimal health in childhood is critical to reduce risk for future chronic disease. To realize the maximum scientific potential of the GRAPHS cohort, we will improve data management to enable broad data sharing.

Public health relevance
The proposed research project will improve public health by improving data management and availability in the GRAPHS cohort, to ensure that the valuable cohort data are available to the broader scientific community. This will improve the ability of the GRAPHS cohort data to inform cost-effective policies to promote optimal development and improve health.